Role of Hyperinsulinemia in NAFLD: Pancreatic Clamp Pilot & Feasibility Study

PROJECT SUMMARY/ABSTRACT
Non-alcoholic fatty liver disease (NAFLD) is an under-appreciated complication of lipid
dysmetabolism in type 2 diabetes (T2DM). Although it appears that insulin resistance (IR) is a
mechanism common to both, the pathophysiology linking it to unhealthy fat accumulation in
liver remains unclear. We propose that the hyperinsulinemia that accompanies IR drives the
excessive hepatic de novo lipogenesis (DNL) that characterizes IR-associated NAFLD (IR-
NAFLD). Our objective, therefore, is to observe the impact of lowering insulin levels on hepatic
lipid metabolism in patients with insulin resistance (prediabetic state plus hyperinsulinemia)
who are diagnosed with, or are at high risk for, NAFLD; we will accomplish this by using the
somatostatin analogue- (octreotide-) assisted "pancreatic clamp" technique. In order to optimize
pancreatic clamp conditions, we must first perform a pilot & feasibility study in which we test
the effect of identifying and (1) maintaining the basal insulin infusion rate (IIR) ("maintenance
hyperinsulinemia", MH protocol) versus (2) a stepwise decline in IIR to 90%, 75%, and 60%
("reduction toward euinsulinemia", RE protocol) of basal. All participants will be tested with both
MH and RE protocols, in random order, separated by 2-4 weeks. We will evaluate changes in
levels of glucose, insulin, and various lipid-metabolic parameters in order to gauge the insulin
dose-glycemic response of insulin lowering and select the appropriate IIR to apply to the RE
protocol in the main study.

Public health relevance
PROJECT NARRATIVE Type 2 diabetes mellitus (T2DM) affects more than a half-billion people in the world, and non- alcoholic fatty liver disease (NAFLD) perhaps a greater number still. With a common foundation in insulin resistance, we propose that T2DM and NAFLD represent two edges of the same sword: the hyperinsulinemia that combats the hyperglycemia of diabetes provokes triglyceride accumulation in the liver. Thus, hyperinsulinemia reduction, if achievable without intolerable hyperglycemia, may represent a novel therapeutic approach to NAFLD.